Health Economics of Substance Use Disorder, HCV, and HIV Treatment: Supporting Financial Sustainability, Advanced Methods, and Knowledge Translation

In the 10 years since our initial award, we have established and sustained CHERISH (Center for Health Economics of Treatment Interventions for Substance Use Disorder, HCV, and HIV) as a National Center of Excellence for health economics research related to substance use disorder (SUD), HCV, and HIV care of people who use substances. Our unique multi-institutional center leverages outstanding researchers in synergistic areas of expertise. In the initial award period, we addressed the needs of integrated healthcare system payers and providers; in the current period, we have expanded our focus to include individual-, system- and community-level concerns. In this renewal, we will emphasize financial sustainability, advanced methods, and knowledge translation, as well as development of the next generation of researchers in our field. Reflecting both the expansion of our network of collaborators and the maturity of our field, Center Specific Aims address service to the research community and advance methods that improve the quality and relevance of economics research on SUD and HCV/HIV care of people who use drugs (PWUD).
Aim 1: To facilitate and develop innovative methods for substance use economics research that supports financial sustainability of evidence-based interventions for SUD and HCV/HIV care of PWUD.
Aim 2: To apply and advance substance use economics research that uses population-level data and simulation modeling to improve economic outcomes and advanced research methods in SUD, and HCV/HIV care for PWUD.
Aim 3: To engage in and improve knowledge translation between health economics researchers and decision makers that enhances evidence-based decision making about SUD and HCV/HIV care for PWUD.
Aim 4: To provide resources, training, and mentoring that develop the next generation of investigators to conduct rigorous and impactful SUD and HCV/HIV economics research.
Each Center Aim will be led by a specific Core that will develop and maintain research partnerships and cross-Center collaborations to support the aim: Methodology Core (Aim 1), Population Data & Modeling Core (Aim 2), Dissemination & Policy Core (Aim 3), and Pilot Grant, Training & Mentoring Core (Aim 4). The Administrative Core provides the leadership, management, and support structure that ensures productive cross-Core coordination and now will be the home for our highly successful and uniquely national CHERISH Consultation Service and Research Affiliates Program, which draw on and provide expertise across Cores. The Administrative Core also leads evaluation of Center activities in concert with a Center Advisory Board.

Public health relevance
In the 10 years since our initial award, we have established and sustained CHERISH (Center for Health Economics of Treatment Interventions for Substance Use Disorder, HCV, and HIV) as a National Center of Excellence for health economics research related to substance use disorder (SUD), HCV, and HIV care of people who use substances. In this renewal, we will emphasize financial sustainability, advanced methods, and knowledge translation, as well as development of the next generation of rigorous researchers in our field. The Center includes 3 Scientific Cores (Methodology Core, Population Data & Modeling Core, and Dissemination & Policy Core) and 2 Supporting Cores (Pilot Grant, Training & Mentoring Core and Administrative Core).